Development of a Group Emotion-Focused Behavioral Intervention for Diabetes Distress and Glycemic Management in Patients with T2D.

PROJECT SUMMARY
T2D is a major public health problem and is currently the 7th leading cause of death in the US. Despite a range
of efficacious treatments, less than 50% of patients achieve a glycemic target of A1c < 7.0%, suggesting that this
is due to difficulty with following medical regimens to reduce A1C levels. While a range of factors have been
identified in this regard, we posit that a barrier to treatment are broad difficulty with emotional regulation that are
not diagnosis-specific but lead to Diabetes Distress (DD) and difficulty in coping with medical regimens, and
other aspects of diabetes self-care, in the context of the psychosocial stressors associated with T2D. Extant data
suggests that sub-optimal emotional regulation (experience of intense emotion and skill at regulating emotion)
is related to elevated DD and A1c levels, and that an Emotion-Focused Behavioral Intervention (EFBI) can reduce
both DD and A1c levels in PWD with T2D. In this project we seek to, first, adapt our EFBI, initially developed as
a one-to-one intervention, to a group intervention (G-EFBI) and, two, collect feasibility, acceptability, and
preliminary efficacy data to determine if G-EFBI is a feasible, acceptable and, possibly, efficacious intervention
compared to an “Attentional Control” intervention in PWD with T2D and elevated DD and A1c levels.

Public health relevance
PROJECT NARRATIVE We posit that a barrier to the treatment of T2D diabetes relates to broad difficulties with emotional regulation (ER) that are not diagnosis specific but lead to Diabetes Distress (DD) and difficulty in coping with medical regimens, and other aspects of diabetes self-care, when confronted with the psychosocial stressors associated with having diabetes. Recent work suggests an important relationship between emotional regulation, elevated DD scores and elevated A1c levels – characteristics that may impact up to 25% of all those with T2D; preliminary data using emotion-focused interventions suggest that elevated DD and A1c levels can be reduced in PWD with T2D. In this project we propose to adapt our emotion-focused behavioral intervention (EFBI) from a one-to-one intervention (I-EFBI) to a group intervention (G-EFBI) and to conduct a pilot RCT study to determine if G-EFBI is a feasible, acceptable and, possibly, efficacious intervention compared to an “Attentional Control” intervention in PWD with T2D and elevated DD and A1c levels.